Immune signatures of vaccine responses in children with sickle cell disease

PROJECT SUMMARY/ABSTRACT
Our focus is identifying molecular signatures defining sickle cell disease and reduced vaccine response by
investigating multiple components of innate immunity and the quality and quantity of long-term adaptive immunity
among children with sickle cell disease. We propose a deep interrogation and a systems biology approach to
characterize changes in innate and adaptive immunity and whole-genome transcriptional response induced by
vaccination in a dysregulated inflammatory milieu linked to poor vaccine response. We have assembled an
interdisciplinary investigative group who have an existing successful collaboration infrastructure and has
expertise in human immunology, pediatric vaccine response, sickle cell disease, pneumococcal antibody
response, proteomics, and computational biology to carry out the proposed studies by 1) examining the innate
immune status of children with sickle cell disease; 2) elucidating innate and adaptive signatures of vaccination;
3) defining transcriptomic and proteomic signatures of vaccine response. We will leverage the recent advances
in single-cell and spatial immune profiling methods and shared immunologic and proteomic platforms to create
a novel resource for sickle cell disease patients and other vulnerable populations. We aim to provide
comprehensive mechanistic insights into sickle cell disease-related chronic inflammation and impaired vaccine
response that will lead to new interventions to improve clinical outcomes in this understudied pediatric population
that have increased morbidity and mortality from infectious diseases and impaired responses to vaccination.

Public health relevance
PROJECT NARRATIVE We propose a detailed interrogation and a systems approach to identify molecular signatures of disease outcomes and response to vaccination to support identifying relevant mechanisms for potential therapeutic and vaccination strategies in a dysregulated inflammatory milieu among children with sickle cell disease.